Chemistry-Biology Interface Predoctoral Training Grant 2024-2029

: T32GM133395
Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
The research and education of trainees in our Chemical Biology Interface (CBI) Program transcends molecular scales, from the atomistic to the cellular level. We provide training and exposure in techniques to probe, design, manipulate, or build molecules, biopolymers, biochemicals, macromolecules, and cellular systems, while maintaining a solid foundation in a specific area of dissertation research. The mission of the program is to provide mentorship and assistance in the students’ intellectual and career development for their entire training. Our T32 CBI program, spanning 7 departments and 50 faculty trainers, is committed to expanding the landscape of chemical biology research by providing multiple paths for trainee success. A dedicate leadership team, organized by a program coordinator, efficiently oversees all aspects of the funding. This starts with a flexible approach to admissions that permits more than one entry point into the program, offering plasticity to our fellows to find their niche in science. A flexible yet strong curriculum in CORE chemical biology concepts, delivered using a required Chemical Biology Didactic Course, seamlessly blends lecture, seminar, and laboratory experiences into 1 or 2 credit modular building blocks, with embedded required Responsible Conduct of Research (RCR) and Rigor-Reproducibility training. Elective Boot Camps in Chemical Biology Techniques builds students’ confidence to perform their thesis research. Our curriculum is open to all interested University of Delaware students curious about the chemical biology discipline. Dedicated, selfless faculty who are essential for the success of the program are supported through genuine mentorship training experiences such as “Mentoring Grand Rounds”. This mentoring community provides the foundation for faculty to shepherd students through their tailored individual development plans, assuring they utilize “out of laboratory” experiences such as: 1. Research Sabbaticals that serve to broaden students’ understanding of career options, through dedicated, planned time away from the home research lab and 2. Teaching Sabbaticals that expose students to modern pedagogy, such as Problem Based Learning (PBL). Our alumni help fuel these out of field experiences, assuring consistent mentorship. Our program holistically cares about the entire student as an individual and empowers them by providing individualized career mentoring, to help trainees define their own career goals, and work through any impediments in order to successfully achieve them. Intentional programming has built an environment, where students pioneer new innovation. The CBI Citizen thinks creatively to problem solve. The University firmly believes that the T32 CBI is critical for its training and research missions, and has consistently committed multi-million-dollar matching funds to support our program over its 30-year history, which synergies with IDeA State COBRE funding mechanisms to directly infuse excellence into our chemical biology program, training outcomes, and community.

Public health relevance
T32GM133395 Project Narrative The research and education of trainees in our Chemical Biology Interface (CBI) Program transcends size scales, from the atomic to the cellular levels. We provide training and exposure in techniques to probe, design, manipulate, or build molecules and complex systems. Funds will be used to implement the proposed plan that has a unified core Chemical Biology curriculum, Mentor Training for the faculty, and Multiple Paths to make our CBI Program efficient in producing innovative and cutting-edge thinkers in the chemical biology space.